Epigenetic modulation of amygdalar circuits that control alcohol compulsivity

PROJECT SUMMARY
We propose to investigate the neurobiological basis of alcohol addiction focusing on epigenetic factors that
underlie individual vulnerabilities. A key feature of alcohol addiction is alcohol drinking despite negative
consequences or at the expense of other rewards. These clinically-significant “compulsive” behaviors occur in a
minority of individuals that consume alcohol – a strong indication that individual vulnerabilities are at the core of
disease. Our previous work has shown that behavioral changes associated with alcohol addiction manifest in
response to persistent epigenetic reprogramming of transcription networks in specific brain regions and neuronal
populations. Epigenetic mechanisms integrate genetic risk and environmental factors such as stress and alcohol
itself. Therefore, elucidating the epigenetic networks associated with the addictive state is a major goal of the
research community, but unfortunately current understanding of these networks and the downstream impact on
neurocircuits involved in alcohol dependence remains limited. In preliminary studies, we investigated a
vulnerable minority of laboratory animals that self-administer alcohol despite pairing with punishment (foot-
shock) – a compulsion-like alcohol self-administration behavior. Using a combination of techniques to profile
gene expression patterns in the amygdala of compulsive rats, we identified a critical role for Enhancer of Zeste
2 (Ezh2), the histone 3 lysine 27 (H3K27) methyltransferase and catalytic component of the polycomb repressive
complex 2 (PRC2). Subsequently, we found that pharmacological inhibition of EZH2 attenuates compulsivity in
rats. Therefore, we propose to clarify the role of EZH2 and H3K27 methylation in regulating transcription
programs in the amygdala, a brain region linked to addiction that is critical for integrating response to adverse
stimuli. Using a relatively novel and highly-efficient epigenetic profiling technology called CUT&RUN we will
profile H3K27me3 specifically in amygdalar neurons and non-neuronal cells of compulsive rats. In parallel, the
functional consequence of differential H3K27me3 will be defined using RNA sequencing. Additional preliminary
data show that inhibition of GABAergic protein kinase C delta (PRKCD) neurons in the amygdala reduces
compulsivity. To further investigate the role of PRKCD-neurons, we will selectively manipulate their activity using
chemogenetics, and assess the effects on compulsivity. These experiments will utilize a recently validated
transgenic rat model that we have created where expression of Cre-recombinase is driven by the endogenous
Prkcd promoter. Using the PRKCD-Cre rat and a Cre-inducible nuclear tagging approach, we will define
differential H3K27me3 levels and gene expression patterns specifically in PRKCD-neurons of compulsive rats.
Finally, we will knock down EZH2 specifically in PRKCD-neurons to define its role in compulsivity with brain-
region and cell-type specificity. Since epigenetic enzymes/effectors, including EZH2, have emerged as
druggable therapeutic targets for complex psychiatric diseases such as alcohol addiction, our study could provide
a new avenue for developing much-needed therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Alcohol addiction is a debilitating disorder characterized by long-term changes in brain function that underlie pathological drinking behaviors. Diagnostic criteria for alcohol addiction consistently identify continued alcohol drinking behaviors at the expense of healthy alternative rewards, and continued use despite adverse consequences (“compulsivity”) as key features. We demonstrate that epigenetic enzymes, known to mediate long-term changes in brain function, are associated with individual vulnerability to developing compulsivity. The goal of the proposed studies is to determine the mechanisms by which these epigenetic enzymes reprogram the brain for alcohol disorder, knowledge that may ultimately lead to novel therapeutic strategies.